Improving Care for Veterans by Understanding and Facilitating Transition to Recommended PTSD Treatment

Background: Posttraumatic stress disorder (PTSD) is one of the most common mental health diagnoses
among Veterans. Cognitive processing therapy (CPT) and prolonged exposure therapy (PE) were widely
disseminated in the Veterans Health Administration (VHA) as recommended PTSD treatments. Despite these
efforts, few post-9/11 Veterans diagnosed with PTSD initiate CPT or PE. In the small percentage of Veterans
who receive these therapies, CPT and PE are rarely the first treatment a Veteran receives. A common
treatment sequence identified in implementation research, begins with “stabilization treatment,” combinations
of psychosocial and medication treatments that prepare Veterans for CPT or PE. A gap in existing research is
how treatment sequences, particularly stabilization treatment, influence initiation of CPT or PE.
Significance/Impact: PTSD is an HSR&D priority condition due to its substantial negative biopsychosocial
impact on Veterans lives. Novel strategies are needed to increase engagement, retention, and improve
outcomes from recommended PTSD treatments, and to reduce disparities in access to this care.
Understanding how to most effectively combine and sequence PTSD treatment is an HSR&D identified area of
interest, and a research gap identified in the VHA PTSD clinical practice guideline.
Innovation: Despite consistently identifying stabilization treatment as a common VHA practice, little research
has investigated this treatment sequence. A novel approach to solving existing limitations in PTSD treatment
delivery involves developing an intervention that both acknowledges the ubiquitous presence and benefits of
stabilization treatment, while facilitating timely transition from stabilization treatment to CPT or PE.
Specific Aims: This CDA-2 aims to improve delivery of PTSD services in the VHA, while simultaneously
providing me with training in health services research methods to support my development into an independent
VHA researcher. The proposed research aims are: (1) To qualitatively understand Veterans’ and clinicians’
perspectives on selecting stabilization treatments and how stabilization treatment serves as a barrier or
facilitator of transition to CPT or PE; (2) To develop and conduct a randomized, pragmatic pilot trial of a brief,
Veteran-centered intervention to support transition from stabilization treatment to CPT or PE; and (3) To
identify sociodemographic disparities in treatment sequences and to determine how treatment sequences
influence time to CPT or PE initiation across the VHA.
Methodology: I will then conduct qualitative interviews with a national sample of Veterans (n=30) and
clinicians (n=20; Aim 1). Using rapid qualitative analysis procedures, I will evaluate how treatment sequences,
particularly stabilization treatment, are chosen and how they serve as a barrier or facilitator of transition to CPT
and PE. I will then use knowledge gained from Aim 1 to develop a health services intervention that facilitates
timely transition to CPT or PE. I will test this intervention in a randomized, pragmatic, pilot trial comparing the
intervention (n=20) to treatment as usual (n=20; Aim 2). I will assess the proportion of Veterans who initiate
CPT or PE within a year after beginning the intervention as a primary outcome and feasibility as a secondary
outcome. Using electronic health record data from a national, longitudinal cohort of post-9/11 Veterans who
received VHA PTSD treatment (anticipated n=400,000) from 10/05-12/23, I will identify treatment sequences;
understand how treatment sequence impacts time to CPT or PE initiation using Cox proportional hazard
regression; and identify disparities in treatment sequences based on sociodemographic characteristics (Aim 3).
Implementation/Next Steps: I will apply the knowledge and training gained through this proposal to an
HSR&D Merit application to test the benefits of the developed intervention on a large scale through a multisite
hybrid type-II pragmatic trial. I will collaborate with organizational partners at the Office of Mental Health and
Suicide Prevention to ensure that work supports efforts to promote clinical practice guideline-consistent care.

Public health relevance
Cognitive processing therapy (CPT) and prolonged exposure therapy (PE) were widely disseminated as recommended posttraumatic stress disorder (PTSD) treatments. However, post-9/11 Veterans with PTSD rarely initiate CPT or PE, especially as an initial treatment. Little research has explored the combinations and sequences of psychosocial and medication treatments that Veterans receive (“treatment sequences”). One common and understudied treatment sequence begins with stabilization treatment, which is designed to prepare Veterans for CPT or PE. There is a significant research gap in understanding how treatment sequence affects initiation of CPT or PE. The proposed research is an innovative, mixed-methods approach to assessing the impact of variability in treatment sequence, including stabilization treatment, on initiation of CPT or PE and applying this knowledge by developing a health services intervention that facilitates timely transition to CPT or PE. Research aims can improve PTSD treatment by increasing initiation of and reducing disparities in CPT/PE.